Pharmacology of Stimulant Choice

This new R01 application proposes a systematic series of experiments focused on drug-choice procedures in
male and female rats to evaluate the muscarinic acetylcholine receptor (mAChR)1 agonist VU0364572 as a
candidate medication for treatment of cocaine and methamphetamine use disorder. This application is founded
on the premise that stimulant use disorder in humans can be studied using preclinical assays of drug-vs-food
choice that model clinical aspects of behavioral misallocation and decision making between concurrently
available drugs and an alternative nondrug reinforcer. We propose to determine 1) VU0364572 effects on
cocaine-food and cocaine-social choice, 2) VU0364572 effects on methamphetamine-food and
methamphetamine-social choice, and 3) VU0364572 effects on nucleus accumbens and prefrontal cortex
dopamine release using dLight.

Public health relevance
Deaths attributed to stimulant misuse are also increasing at an alarming public health rate. This application proposes research to evaluate the effectiveness of muscarinic acetylcholine agonists to treat stimulant misuse.